Discovering miRNA-Mediated Mechanisms of Interneuron Development

Project Summary
Inhibitory interneuron (IN) development requires successful completion of a series of
processes, which include long-range migration, lamination, molecular specification, circuit
integration, and functional maturation. IN dysfunction is highly implicated in neurodevelopmental
and psychiatric disorders, so understanding how INs achieve their mature distribution, number,
and identity is critical to understanding disease. Cell-intrinsic gene expression programs, involving
the precise regulation of huge sets of genes, interact with environmental cues to control
development. MicroRNAs (miRNAs) are post-transcriptional regulators of gene expression known
to be necessary for multiple aspects of IN development, yet the specific mechanisms by which
miRNAs do this remain unknown, in part because IN-specific patterns of miRNA activity were
unknown. We bridged this gap by performing Ago cross-linking and immunoprecipitation followed
by sequencing (Ago CLIPseq) to comprehensively profile the IN targetome at developmental
timepoints. However, identifying developmental pathways regulated by individual miRNAs has
been challenging because the targetome is extremely complex—miRNAs simultaneously regulate
many genes and can compensate for each other through co-targeting relationships. We propose
an alternative approach of investigating miRNA regulation on a gene-by-gene level. Through
bioinformatic analysis of the CLIPseq data, I identified miRNA hotspots, or genes co-targeted by
multiple miRNAs, which we hypothesize is a signature of strong miRNA regulation shared by
many key developmental genes. With these candidate genes, I am now poised to untangle how
miRNA regulation of specific genes controls particular aspects of IN development. I will use new
CRISPR-based methods for disrupting miRNA regulation of candidate genes in a cell type-specific
manner and screen for developmental defects, first using a set of in vitro and in vivo readouts for
IN migration, survival, and subtype specification. Then, I will assess perturbations of overall
developmental trajectory using targeted Perturb-seq, which harnesses the transcriptome as a
complex readout of maturation state in single cells. Ultimately, with this experimental pipeline I
will discover genes and miRNA mechanisms that control IN development.

Public health relevance
Project Narrative The proposed project aims to discover mechanisms by which microRNAs (miRNAs) regulate the development of cortical inhibitory interneurons (INs), using a suite of sequencing methods, CRISPR-based manipulations, and developmental assays. IN dysfunction is closely associated with a wide range of multiple neurodevelopmental and psychiatric diseases, and recent research has found altered miRNA activity in many patients, so these results will potentially provide valuable insight on disease mechanisms and uncover new targets for further translational research. In addition, this work will validate an innovative conceptual framework for understanding miRNA function, as well as a gene discovery platform with potential to accelerate research on brain development and complex gene expression programs.